IGF::OT::IGF WA: CT003-401-424-003, CLINICAL DRUG SUPPLY, DTP-15-036, 06/30/15 - 12/30/15, TABIBI, PRB

The Contractor will produce nominal one thousand (1000) vials of lyophilized Mithramycin A according to the attached batch record under the cGMP condition for clinical use.